MOLECULAR BASIS OF SELECTIN INTERACTION WITH LEUKOCYTES

The objective of this project is to define the biochemical and biophysical mechanisms through which the selectins initiate rolling of leukocytes on the vessel wall under shear forces. Rolling is a prerequisite for stable adhesion and, ultimately, for emigration of leukocytes into the tissues in response to infection or injury. The work will focus on the interactions of P- and E-selectin, which are expressed on activated platelets and/or endothelial cells, with PSGL-l, a mucin- like glycoprotein expressed on leukocytes. We have shown that these interactions are critical for neutrophil rolling on P- or E-selectin. We have purified native or recombinant forms of PSGL-l and the selectins, and have developed monoclonal antibodies to each molecule. We will determine whether the consensus repeats and EGF domains of E and P- selectin affect their kinetics and affinities of binding to PSGL-l, and we will explore the structural basis for high affinity binding of Ca2+ to the lectin domains of the selectins. We will map the binding sites for mAbs and for the selectins on PSGL- 1, and seek to express a recombinant PSGL-1 that is glycosylated such its function resembles that of the native myeloid cell glycoprotein. We will examine the structural requirements for E- and P-selectin to mediate rolling of myeloid cells under shear stresses. Finally, we will examine the mechanical strength of binding of purified PSGL-1 incorporated into liposomes to P-selectin incorporated into planar membranes, under shear forces or using micromanipulation techniques. This project is closely linked with Project 4, where the structures of the glycans of PSGL-I will be determined. Within the context of the program project, this work is designed to extend our knowledge of protein-carbohydrate interactions, biomechanical factors affecting cell-cell adhesion under shear stress, and the recruitment of inflammatory cells to the vessel wall.